Development of a Novel Oral Antibiotic for the Treatment of Drug Resistant Gonorrhea

PROJECT SUMMARY / ABSTRACT
The CDC has identified Neisseria gonorrhoeae as a pathogen of the highest threat level (“Urgent Threat”) to
the US public health. Currently there is only a single recommended agent remaining on the CDC treatment
guidelines, an intramuscular injection of the extended spectrum cephalosporin, ceftriaxone. However, in the
past decade, reports of resistance to ceftriaxone have appeared across the globe. If one of these strains were
to disseminate widely, we would be facing an era of untreatable gonorrhea. Untreated infections can cause
serious and life-threatening sequelae. Thus, developing new antibiotics without cross-resistance to the current
therapeutics is of critical importance to public health. Between 20 and 40% of individuals infected with N.
gonorrhoeae are co-infected with Chlamydia trachomatis, a predominantly asymptomatic infection that can
have devastating long-term effects on reproductive health and fertility if not treated. Ceftriaxone is not active
against C. trachomatis and the clinical signs and symptoms of gonorrhea and chlamydia are indistinguishable
from one another. Therefore, unless chlamydia can be excluded by a laboratory diagnosis, empiric treatment
for gonorrhea typically involves administration of two different classes of antibiotics in order to cover both
pathogens. A single oral antibiotic effective against both infections would change the current treatment
paradigm, improving adherence to treatment as well as reducing the impact that dual antibiotic therapy can
have on promoting resistance in co-infecting pathogens and commensal organisms. Furthermore, as an oral
antibiotic, it would provide a much-needed treatment option to patients and physicians and allow for expedited
partner therapy. AimMax Therapeutics has discovered a novel antibiotic with activity against N. gonorrhoeae
that is comparable to ceftriaxone. It has demonstrated potent activity against multidrug- and pan-resistant N.
gonorrhoeae isolates, including isolates resistant to ceftriaxone, with no evidence of cross-resistance to
existing classes. The overall goal of this proposed FastTrack SBIR application is to develop a novel oral
antibiotic for the treatment of gonorrhea as the top priority, and if suitable, for the treatment of chlamydia also,
the two most common bacterial sexually transmitted infections in the US. The studies proposed herein will
confirm the suitability of this new class of antibiotic for the treatment of gonorrhea and chlamydia, identify a
formulation that delivers optimal oral bioavailability and plasma exposure to provide effective treatment, and
advance development towards filing of an IND. Rising antibiotic resistance combined with ease of
transmission, risks for outbreaks, and lack of second-line treatment options, all point to the critical need to
identify new antibiotics for the treatment of gonorrhea and expeditiously advance their development to the
clinic.

Public health relevance
PROJECT NARRATIVE The emergence of multidrug resistant Neisseria gonorrhoeae, including strains resistant to the injectable antibiotic ceftriaxone, the only remaining treatment recommended by the CDC, represents a serious and urgent threat to US public health. With more than 600,000 new cases of gonorrhea in the US each year, the spread of an untreatable strain would have devastating consequences, highlighting the need for prompt action to identify and develop new classes of antibiotics to treat this disease. We aim to develop a novel oral antibiotic for the treatment of drug-resistant N. gonorrhoeae to address the urgent threat of untreatable gonorrhea.